Administrative Core

Modified Project Summary/Abstract Section
The Administrative Core is responsible for managing and overseeing the SPORE, disseminating information
within the SPORE, and interacting with external agencies, advisors, and related personnel. This Core is led by
Dr. Ie-Ming Shih (Contact PI) from JHU and Dr. Ronny Drapkin (SPORE mPI) from UPENN, who have had
extensive experience in research administration, fiscal management skills, and leadership in multi-institutional
research projects. The Administrative Core serves the entire SPORE Program in several key areas of coordination
and oversight. It will interact with the Biorepository/Pathology Core and the Biostatistics Core, as well as with
investigators from each research project. The Core leaders are responsible for planning, managing, and directing
the overall operations of the program. They will ensure the attainment of strategic objectives and the delivery of
quality administrative support to all research projects, programs (CEP and DRP), and other Cores, as well as
promote resource sharing, new research opportunities, and patient advocacy. This Core will also coordinate
essential program interactions, including all planning and evaluation activities, arranging and publicizing SPORE
activities, monitoring data and safety, coordinating advisory committee meetings, summarizing annual reports,
and performing analysis of budgetary matters. Overall, through the functions mentioned in the following
description, the Administration Core will provide an essential service to each of the Research Projects and Core
Resources to facilitate the accomplishment of the proposed goals and objectives of the SPORE as a whole, to
effectively communicate with other entities, and to disseminate exciting findings to stakeholders.

Public health relevance
Modified Public Health Relevance Section The relevance of this Administration Core to public health is to facilitate the entire SPORE program to complete their proposed research projects, thereby enhancing awareness, early detection, and prevention of ovarian cancer among the population.